IMMUNOREGULATION AND IMMUNE RECOGNITION IN FILARIASIS AND NON-FILARIAL DISEASES

The purpose of this project is to delineate the mechanisms involved in regulating the humoral and cellular responses in patients with filariaisis and other disease states. Immunoregulatory studies have examined the phenomenon of antigen-specific anergy in microfilaremic patients by showing this anergy at the level of antibody (B cell) and lymphokine (T cell) responsiveness. Further, similar T cell anergy has been found among patients with active onchocerciasis. The influence of genetic factors, antigen composition, and specific antifilarial chemotherapy on this anergy has begun using molecular biological tools and defined antigens. In vitro models of parasite-antigen driven antibody production as well as parasite-specific and HTLV-1 transformed T cell clones have been developed to understand in more detail those mechanisms regulating antibody production (particularly lgG andlgE) in filarial and non-filarial diseases. Qualitative analysis of filaria-specific lgE and lgG in loiasis, lymphatic filariasis, and onchocerciasis have indicated patterns of antigen recognition which differ among groups of patients with different clinical manifestations of filariasis. Using these techniques, antigens recognized exclusively by patients with loiasis or onchocerciasis have been identified. Fliarial species- specific antigens recognized by human monoclonal antibodies derived from EBV-transformed patient B cells have also been identified and characterized. Further, FPLC fractionation and qualitative analysis of the antigenic components of filarial parasites has identified a two sets of proteins which appears to regulate the immune response at both the cellular and humoral level.